Admin Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The UTSW NORC Administrative Core promotes and supports interdisciplinary research in nutrition, obesity,
and obesity-induced diseases to facilitate the translation of basic scientific discoveries into improved clinical
outcomes. The NORC Director, Co-directors, Administrator, Core Directors/Co-directors, with governance
by the Executive Committee, are responsible for coordinating Internal and External Committee Meetings,
monitoring and documenting the use of each core, overseeing the Enrichment Program, managing the Pilot
& Feasibility Program, tracking publications that were facilitated by NORC funding, and reporting annually to
the NIH.